ACTG 242--PHASE II/III DOUBLE BLIND STUDY OF AMITRIPTYLINE AND MEXILETINE

The primary objective of this study is to assess the effectiveness of amitriptyline and mexiletine in reducing pain intensity in patients with HIV-related painful neuropathy, as measured by the pain intensity description scale developed by Gracely et al. The study will also assess the safety and tolerability of study treatments.